Imaging and manipulating oncoprotein phase separation and compartmentalization

Abstract
MYC oncoproteins including c-Myc and MYCN are major drivers of human tumorigenesis. Expression of MYC
is deregulated and enhanced in many types of human cancer. For instance, MYCN is a major driver of
childhood cancers. While upregulated MYC expression induces tumor development in many tissues, depletion
of MYC abolishes tumorigenesis and results in tumor regression in various tumor models. Despite significant
progress in understanding the link between MYC upregulation and tumorigenesis, many key questions remain
regarding how upregulated expression of MYC leads to tumorigenesis. The relationship between MYC
upregulation and its transforming activity has not been investigated in a quantitative manner, which is important
because one potential consequence of elevated expression is protein phase separation that occurs when
protein concentration is above critical concentration. Recently, many transcription factors that contain
intrinsically disordered region (IDR) have been reported to undergo concentration-dependent liquid-liquid
phase separation (LLPS), forming biomolecular condensates (also known as membraneless compartments,
liquid droplets). MYC oncoproteins are transcription factors and contain IDR and our preliminary study reveals
punctate structures of MYCN in the nucleus of Kelly MYCN-amplified neuroblastoma cells, suggesting that
MYCN forms condensates in the Kelly cells where MYCN is highly expressed. Functions of biological phase-
separated condensates include compartmentalized signaling. Condensates of transcriptional factors have been
proposed to compartmentalize transcriptional machineries and remodel gene transcription. MYC oncogenic
signaling relies on its interaction with the key proteins including MAX and TRRAP for the transcriptional activity
and transforming, and inhibition of these interactions results in MYC inactivation. To understand upregulated
MYC oncoproteins and their link to tumorigenesis, several basic molecular biological questions need to be
addressed regarding biophysical/chemical mechanisms and functional roles of MYC condensates, including: 1)
Whether and how MYC undergoes phase separation and forms condensates in biochemical and cellular
systems; 2) Whether MYC condensates compartmentalize transcriptional machineries; 3) Whether MYC phase
separation remodels downstream gene expression and whether condensates of MYC is necessary for the
transforming activity. Because LLPS is dependent on protein concentration, biological functions of phase
separation are often entangled with effects from changes of expression levels. To dissect MYC LLPS and
functional consequences, there is a need for chemogenetic tools that can manipulate MYC LLPS without
changing protein levels, and ideally such manipulation can be performed in two opposite directions: driving
condensate formation and dissolving existing condensates. Here we propose to develop such chemogenetic
tools and combine them with fluorescent protein labeling technology and multicolor fluorescence imaging to
dissect biochemical mechanisms and functional roles of MYCN condensates.

Public health relevance
Public Heath Relevance/Narrative MYCN is a major driver of childhood cancers including neuroblastoma. However, currently no drugs have been approved against the MYCN oncoprotein. Successful completion of this project will provide quantitative understanding and new insights into MYCN oncogenic signaling and how MYCN regulates gene transcription and transforms cells, and may lead to new approaches to therapy.